Pandemic preparedness in schools: A community based approach for sentinel surveillance

PROJECT SUMMARY
The COVID-19 pandemic prompted governments to implement a range of public health measures, including
school closures, to slow the spread of SARS-CoV-2. However, the role of in-school transmission of SARS-CoV-
2, what mitigation levels and testing policies are needed, and the value of school closures have been
contentious issues. In-person school closures or quarantine policies that prevent students from being in school
can have immediate and long-lasting negative impacts on child development. In New York City, the calculated
magnitude of student-level learning losses due to COVID-19 and the transition away from classroom-based
instruction was on average 125 (69%) and 212 (118%) days of reading and math, respectively, relative to a
typical 180-day school year. Across the United States, reduced educational attainment is estimated to translate
into a loss of four to five percent of lifetime earning wages. Thus, opening schools to in-person learning is an
important step in re-opening the economy and promoting development and success of students; however, it
comes with the danger of increasing contact networks and transmission opportunities. To assess this trade-off
and the potential for increased transmission, we will build models to incorporate school-level infection
monitoring data along with community-level testing data, vaccination data, immunological and serological
indicators among students and faculty, in addition to built environment indicators of school settings. These
models will allows us to determine associations between community-level transmission rates and test positivity
rates within schools (Aim 1), develop an epidemiological disease transmission model that identifies how to
cost-effectively collect sentinel school surveillance data (Aim 2), and identify policy trigger points to predict
when interventions should be implemented in schools to prevent disease transmission (Aim 3). Although I have
the requisite engineering background and experience developing infectious disease models, additional training
will maximize success of the proposed project and catalyze a robust independent research program. To
accomplish these goals, I will obtain additional training in biological sciences and public health, particularly in
community engagement, immunology, virology, and epidemiology. I will develop these skills through didactic
training, independent study, and mentorship from experts in these fields: Drs. Maida Galvez, Rachel Vreeman,
Jeffrey Shaman, Andrea Graham, Nicole Bouvier, and Chris Gennings. At the end of this training period, I will
be uniquely positioned to comprehensively examine the effects of respiratory disease transmission in future
research. Further, I will use the knowledge gained and the developed disease transmission models in future
grant applications, establishing a crucial step toward my long-term goal of optimally designing infectious
disease monitoring networks to reduce the spread of disease and improve the health of communities.

Public health relevance
Public Health Relevance Statement/ Narrative The recent emergence of SARS-CoV-2 has created a public health emergency, making it challenging to keep schools open for in-person learning. This proposal will assess the trade-offs associated with different policies to keep schools open and kids in the classroom with the potential for increased transmission, by integrating school-level infection monitoring data with community-level testing data, vaccination data, and immunological and serological indicators among students and faculty. Model simulations will be used to identify cost-effective strategies, while accounting for community concerns for optimal sentinel surveillance, with an aim to minimize student infection risk while maximizing time in school.